SRI 2023 RODENT AND NON-RODENT PHARMACOKINETIC STUDIES

Performance Area 1 Management and Operations Support for Pharmacology and Toxicology for
Therapeutics Program (PTTP)."

Public health relevance
Developing therapies for neurological disorders